Graft-versus-Host Disease: Local Maintenance by Tissue Resident Progenitor T cells

Abstract
Allogeneic hematopoietic stem cell transplantation (alloSCT) can be a curative therapy for hematologic
malignancies and inherited and acquired disorders of blood cells. Alloreactive graft T cells mediate the graft-vs-
leukemia (GVL) effect and promote hematopoietic engraftment. However, they also attack normal host tissues
causing graft-vs-host disease (GVHD). A central goal of alloSCT research has been to discover methods of
minimizing and treating established GVHD with relative sparing of GVL and anti-pathogen immunity. This has
been a challenge as most GVHD therapies target basic T cell functions. Development of more specific
approaches will require a better understanding of GVHD biology. We considered the question of how GVHD is
maintained once established. One possibility is that GVHD is sustained by the continuous generation of
alloreactive effector T cells (Teff) in secondary lymphoid tissues (SLT), which then traffic to GVHD target tissues
via blood. Alternatively, once tissues are seeded with alloreactive T cells, GVHD is maintained locally without
significant input from SLT-derived T cells. A challenge to either model is that chronic alloantigen stimulation
induces T cell exhaustion. We found through analysis of T cell clones in a CD4+ T cell receptor transgenic
(TCR Tg; “TS1” T cells) GVHD model and through parabiosis of mice with GVHD induced by congenic TS1
cells or polyclonal CD4 and CD8 cells, that once established, GVHD is dominantly maintained locally within
tissues with only a small ongoing contribution from blood-derived alloreactive T cells. We identified a tissue-
resident Tcf7-expressing (protein is TCF-1) progenitor-like T cell subset (Tpro) in all tissues that we believe is
critical for intratissue GVHD maintenance. These cells share features with TCF-1+ “progenitor exhausted” (Tpex)
CD8+ T cells described in chronic viral infections and in anti-tumor responses. Tpex develop in the setting of
sustained antigen stimulation (also the case with GVHD) and are dependent upon the transcription factor TOX,
which we found to be upregulated in alloreactive T cells. Taken together, our data support a model wherein
GVHD begins as a systemic immune response initiated by alloreactive T cell clones distributed from SLTs,
which morphs into a systemic disease that is the sum of locally maintained intratissue T cells responding to
continued local antigen exposure. Tissue-resident alloreactive Tpex would be ideal targets for GVHD prevention
(by blocking their formation) and treatment (impair Tpex once formed). Achieving these objectives requires a
detailed and mechanistic understanding of alloreactive Tpex/Tpro development and of the extrinsic signals and
transcription factors that govern their survival, self-renewal, and differentiation into Teff. We will rigorously test
the role of Tcf7 and Tcf7+ cells by inducibly deleting Tcf7 from T cells after GVHD is established. We will fate-
map Tcf7-expressing cells using Tcf7-ERT2cre transgenic mice and perform genomic analysis on Tpro and their
immediate Teff progeny. We will test the role of TOX using TOX-/- T cells and the role of antigen by varying
antigen exposure. We will apply these techniques in the TS1 TCR Tg model and a polyclonal GVHD system.

Public health relevance
Project Narrative Many patients with blood cancers or inherited defects in blood cells, such as sickle cell anemia, are treated with a blood stem cell transplant from another person; however, immune cells from the donor can attack the patient causing damage to organs and even death. This grant explores how this immune damage is sustained within each affected tissue by stem cell-like immune cells. This knowledge could make this procedure safer and available to more people with a greater variety of illnesses.